TREATMENT OF BLADDER CARCINOMA WITH HUMAN NECROSIS FACTOR

This study will determine the safety, tolerance, pharmacokinetic profile, biological effects, and maximally tolerated dosage levels of escalating single doses of recombinant human tumor necrosis factor administered by weekly 1-hour intravesical installations into the bladder of patients with histologically documented superficial bladder carcinoma or carcinoma in situ.